Next-Generation 3 Tesla Human MRI Scanner for Mental Health Research

PROJECT ABSTRACT
This grant will support the purchase of a next-generation Siemens 3 Tesla human MRI scanner for mental health
research in the integrated PET-MRI facility at the Athinoula A. Martinos Center for Biomedical Imaging. The
proposed instrument will replace an existing, 16+-year-old obsolete 3 Tesla MRI scanner that is reaching end-
of-support status by the vendor and has seen diminishing usage over the last 5 years. We have recently secured
a replacement for the 15+-year-old Siemens BrainPET prototype that currently resides in this obsolete 3T
scanner. To make full use of the integrated capabilities of the PET-MRI system and expand our capacity for a
continually growing base of users, we now seek to upgrade the 3T MRI scanner to a next-generation 3T system
equipped with high-performance gradients up to 200 mT/m in strength and 200 T/m/s in slew rate. The proposed
system exceeds the capabilities of current commercially available 3T MRI systems and will represent the first
system of its kind to be integrated with a PET system, enabling investigations into the cellular-scale structure
and circuitry of the human brain with unprecedented detail and molecular specificity. The instrument offers a
substantial increase in performance for investigators at Mass General Brigham and the greater Boston area,
justified on a shared-use basis by over 25 users and 30 NIMH- and NIH-funded projects in PET-MR. The breadth
of supported mental health research spans translational neuroimaging, therapeutic neuromodulation, and
cognitive, psychiatric, and basic neuroscience studies in mental disorders such as major depressive disorder,
bipolar disorder, autism spectrum disorder, schizophrenia, obsessive-compulsive disorder, and Alzheimer’s
disease. The system to be replaced uses outdated hardware and software and has required excessive servicing
with downtime of up to 30%, placing substantial pressure on our other 3T systems, which are highly utilized and
cannot accommodate our expanding user community. The next-generation 3T MRI features: higher performance
gradients; enhanced RF architecture; higher density specialized coils; the latest standardized hardware and
software for multi-site studies; faster computer enabling modern imaging techniques; integrated physiological
monitoring; new sequence and application packages for accelerated, multi-contrast exams; and an up-to-date
testbed for the unique technology development performed at the Martinos Center. The new instrument is
supported at a high level by MGB leadership, the Radiology Department, and the Martinos Center, covering the
allocation of space and costs for installation, operational support, and maintenance, including an exceptional
financial commitment to cover the gap between the NIH instrumentation award and purchase price of the
upgrade. By serving a highly productive interdisciplinary group of NIMH- and NIH-funded investigators, the
proposed upgrade will offer a cutting-edge research resource that will push the frontiers of investigating brain
structure-function relationships at finer scales and higher sensitivity and specificity, thereby providing our
investigators with the technological edge required for innovative research in mental health and mental disorders.

Public health relevance
PROJECT NARRATIVE This project supports the purchase of a next-generation 3 Tesla human MRI scanner at the Athinoula A. Martinos Center for Biomedical Imaging to serve a diverse array of NIMH- and NIH-funded studies at Mass General Brigham and across the greater Boston area research community. The new 3 Tesla human MRI will replace the obsolete scanner in the Martinos Center PET-MR & Radiochemistry Facility. It will also boost the imaging performance and provide major benefits to structural, functional, and multimodality PET-MR imaging and microstructural tissue characterization for understanding mental health and psychiatric disorders.